GENETECH POST TREATMENT FOLLOW-UP STUDY

Obtaining current height, pubertal stage, bone age and medication use for statured studies is very important to assess thoroughly the effects of Protropin & Nutropin patients previously enrolled in statured Genetech protocols are being followed in this study.